Novel Signaling Mechanisms of Stat Transcription Factors

Abstract: Cytokine activation of the Jak/Stat pathway is a key signaling network that controls many homeostatic programs required for development, differentiation and orchestrating responses to pathogens. Activation of sets of early response genes by the Stat transcription factors is a key endpoint for initiation of these numerous responses. We have made the observation that in addition to their actions as transcription factors some Stats regulate the transcription of mitochondria-encoded genes and ATP production. We hypothesize that mitochondria-localized transcription factors play an important role in adaptive responses to pathogens. Using mouse models this proposal will examine the physiological importance of Stat regulation of mitochondrial respiration.

Public health relevance
Project Narrative: Communication between different subcellular organelles is important for responses to environmental stresses such as pathogens. We have made the observation that the Stat family of nuclear transcription factors also reside within the mitochondria where they modulate energy production. This proposal will examine the contribution of mitochondrial-localized Stat3 to its well know actions in regulation of development and infection.